ENZYMOLOGY OF HOMOLOGOUS RECOMBINATION AND DNA REPAIR IN DROSOPHILA MELANOGASTER

The effects of DNA sequence on enzymatic function has been an area of extensive research. Recent studies reveal strong DNA sequence effects on the 3~-exonuclease activity of Rrp1. The exonuclease acts on pyrimidine rich regions much more slowly than on purine rich regions. This enzymatic property is conserved between Rrp1 and it~s homologue, E. coli exonuclease III, however, its biological importance is not yet clear. Using a genetic screen, we isolated mutants of Rrp1 with altered DNA repair capacity. These mutants identify amino acids that modify the nuclease function and identify a glutamic acid residue essential for all nuclease function. Recently published crystallographic data supports this enzymatic analysis with structural information and indicates a critical role in the active site for the same glutamic acid residue. In recent enzymatic studies of Rrp1, a 3-phosphodiesterase assay was developed with higher sensitivity and specificity than standard assay methods. Application of this assay using extracts from yeast allowed identification of a novel repair enzyme with properties similar to Drosophila Rrp1. Partial purification yields a protein fraction enriched in a Mg++ dependent 3-phosphodieserase with associated class II AP endonuclease and weak 3-exonuclease. Further characterization of this yeast protein is in progress.